Ebola Biosafety and Infectious Disease Response Training

Project Summary The New Jersey/New York Hazardous Materials Worker Training Center (NJNY Center) will conduct worker-based training to prevent and reduce workers’ risk of exposure to Ebola virus and other infectious diseases through their work duties. This application includes the following members of the NJNY Center: • Rutgers School of Public Health (Rutgers) • New York Committee for Occupational Safety and Health (NYCOSH) • World Cares Center (WCC) • Universidad Metropolitana (UMET) Each of these organizations will apply their specific expertise to develop and implement training for their target groups. A total of 92 courses reaching 1,935 trainees will be provided in the first year to workers in Federal Region 2, including New Jersey, New York and Puerto Rico. Courses will be provided both in face-to-face and online environments. Training will include a variety of teaching methods, including small group activities, hands-on, lectures, and discussions.

Public health relevance
The NJ/NY Hazardous Materials Worker Training Center will provide Ebola biosafety and infectious disease training in Federal Region 2. The public health impact of training provided by the Center will prevent and reduce injuries and illness due to potential risks during response to infectious disease outbreaks. Training provided is the vital to educating workers in safety and health issues.